6/7 PsycheMERGE: Advancing Precision Psychiatry

PROJECT SUMMARY
Psychiatric disorders remain a leading cause of disability in the US and are associated with increased morbidity
and mortality. Early detection and treatment is essential to improving long-term outcomes, yet a substantial
proportion of patients with psychiatric complaints experience long diagnostic odysseys before receiving an
appropriate diagnosis and initiating effective treatment. “Learning health care systems” aim to short-circuit this
slow process by leveraging the diagnostic, treatment, and utilization patterns left behind in “big data” (e.g.,
clinical, genomic, and social determinants of health) to more efficiently and accurately match the right patient
with the right diagnosis/treatment, at the right time. Furthermore, over the past several years, a new paradigm–
precision medicine–has moved to the forefront of biomedical research and clinical practice. Precision medicine
has been defined as “an approach to disease treatment and prevention that seeks to maximize effectiveness by
taking into account individual variability in genes, environment, and lifestyle.” Since its inception in 2018, the
mission of the PsycheMERGE network has been to advance precision psychiatry in a learning health care system
framework. This application, which was developed collaboratively by PsycheMERGE Network members,
represents an opportunity for profound advancement of both basic and translational research in precision
psychiatry. We propose extending our foundational efforts to now address barriers to scalability, utility of genomic
data, clinical application, and translation to clinical practice in a precision psychiatry paradigm. Specifically, Aim
1 creates a nation-wide federated transfer-learning platform for the development of generalizable and bias-aware
algorithms. Aim 2 integrates state-of-the-art methods to perform inclusive trans-ancestry genomic analysis of
biobank samples and further innovates by leveraging the breadth and depth of medical record data to discover
novel biology that can further inform precision psychiatry paradigms. Aim 3 addresses the application of
algorithms by focusing on two use cases including (a) differential diagnosis between bipolar disorder 1 and other
mood disorders, as well as (b) probabilistic treatment response to antidepressants for acute depressive
episodes. Lastly, Aim 4 uses mixed methods to assess the feasibility, utility, and attitudes towards precision
psychiatry tools. Our combined sample of clinical EHR data exceeds 29 million individuals and of those, nearly
2 million also have genetic data already available for analysis across the twelve sites included in this application.
A cross-cutting theme throughout the application is the intentional focus on equitable performance of algorithms,
innovative integration of social determinants of health, and inclusive methods for genomic analyses. The sites
included are also representative of many diverse communities across the United States including the East and
West Coasts, the South, and the Midwest. This application represents a major step towards equitable precision
psychiatry and brings the field closer to the goals outlined in the updated NIMH Strategic plan.

Public health relevance
NARRATIVE The mission of the PsycheMERGE Network is to advance equitable precision psychiatry in learning healthcare system frameworks across the United States. During the course of this project, an interdisciplinary team of investigators at twelve academic medical centers will bring together clinical data (>29 million individuals), genetic data (>1.9 million), and an extraordinary range of scientific expertise (psychiatry, medical informatics, machine learning, statistics, genetics, sociomedical sciences, decision sciences, and ethics) to advance this mission. We will leverage this expertise and data to build on our prior success and address barriers to scalability, utility of genomic data, clinical application, and translation to clinical practice.